MATURATION OF DIAPHRAGM NEUROMUSCULAR TRANSMISSION

The purpose of this research project is to study the role of neuromuscular transmission failure in the diaphragm and determine how this role changes with maturation. In addition, I will determine how neuromuscular transmission is modulated by chronic loading. My hypothesis is that neuromuscular transmission failure plays a significant role in the development of diaphragmatic fatigue in adults, and even more so in newborns. My specific aims are to: 1) determine whether neuromuscular transmission failure occurs in-vivo in chronically instrumented awake adult sheep during acute inspiratory flow resistive loaded breathing; 2) study the maturational changes in neuromuscular transmission during acute inspiratory flow resistive loaded breathing in awake lambs (ages <1 wk, 2 wk, 4 wk and 8 wk) ; 3) determine whether chronic inspiratory flow resistive loading improves neuromuscular transmission in the diaphragm in adult and newborn sheep, Measurements of indices of diaphragmatic function and neuromuscular transmission in-vivo (Pdi, EMG, single unit action potentials, phrenic neurogram, ventilation, blood gases) will be done using state-of-the-art techniques. Since this proposal presents an integrated approach to the study of neuromuscular transmission failure ad a function of age, it is highly likely to generate new information which will have direct relevance to our understanding of respiratory muscle function and failure in early life.